Mindful Hand Hygiene to Reduce Infections Among Veterans While Enhancing ProviderWell-Being

Background: More and more providers face cumulative stress and burdens arising from increasing
regulations, administrative and clerical duties, clinical workloads, malpractice lawsuits, and less time with
patients. As a result, stress, fatigue, psychological distress, depression, burnout, and career dissatisfaction
among providers are prevalent. In addition to impacting providers directly, poor well-being can negatively
impact healthcare organizations and reduce quality of care, patient safety and patient satisfaction. Additionally,
provider burnout, stress, and workload have been associated with poorer hand hygiene adherence, which can
increase the risk of healthcare-associated infection (HAI). Hand hygiene is a key element of preventing HAI,
yet maintaining healthcare provider adherence to this basic practice remains challenging. Achieving optimal
hand hygiene adherence requires minimizing cognitive biases, such as perceived low odds of spreading
infections by not properly performing hand hygiene. Unfortunately, cognitive bias is a known barrier to clinician
decision-making. Mindfulness is an approach that can help clinicians shed preconceived biases through
nonjudgmental awareness and more broadly facilitate improvements in patient safety.
Significance: A hand hygiene-based mindfulness intervention targeted at Veterans Health Administration
(VHA) providers could improve hand hygiene practices and thereby enhance patient outcomes. Additionally,
incorporating brief mindfulness practices during moments of hand hygiene has the potential to directly improve
provider well-being.
Innovation and Impact: While targeted interventions and bundled approaches to improve hand hygiene
adherence and reduce HAI have been implemented, interventions incorporating introspective techniques, such
as mindfulness, are limited. In a recent single-site pilot study, team members of this proposed study found that
a brief mindfulness intervention improved hand hygiene and mindful attention among physicians. The proposed
study will expand on this pilot work by more broadly testing the hand hygiene-based mindfulness intervention
with both physicians and nurses, and by including a specific focus on provider well-being. The goal is to
optimize provider hand hygiene adherence, improve provider well-being and enhance the quality and safety of
care delivered to Veterans.
Specific Aims: We have three specific aims: 1) To evaluate the effectiveness of a hand hygiene-based
mindfulness intervention on provider hand hygiene adherence, duration, and perceptions. 2) To evaluate the
effectiveness of a hand hygiene-based mindfulness intervention on measures of provider mindfulness and
well-being. 3) To identify the barriers, facilitators, and perceptions of a hand hygiene-based mindfulness
intervention in the hospital.
Methodology: We will conduct a randomized controlled mixed-methods trial at 2 diverse VHA hospitals.
Physicians and nurses randomized to the intervention arm will receive mindfulness education and tools to
prompt mindfulness during hand hygiene. Measures of hand hygiene (adherence, duration, and perceptions)
and measures of provider mindfulness and well-being will be collected and compared between the intervention
and control groups.
Next Steps/Implementation: We will work with our proposed partners to review our study findings, modify our
intervention as needed, and disseminate our findings through the various partnership channels. At the
conclusion of this project, we will have a hand hygiene-based mindfulness intervention package that we can
subsequently work to deploy more broadly across VHA hospitals to improve the safety of Veterans and the
well-being of those providing their healthcare.

Public health relevance
This study will test whether a hand hygiene-based mindfulness intervention can improve provider hand hygiene adherence, improve provider well-being, and enhance Veteran outcomes. Given the importance of hand hygiene adherence and the increasing levels of provider burnout and stress, this work directly aligns with multiple priorities of the Department of Veterans Affairs (VA) and will enhance Veteran safety. Our findings will shed light on how to more effectively prevent infections through the use of a novel mindfulness intervention focused on increasing hand hygiene adherence and provider well-being.